Admin Supplement to "Breaking up sedentary behaviors to improve glucose control in a population at risk for developing type 2 diabetes"

SUMMARY/ABSTRACT
This proposal requests supplemental funding to support the ongoing NIH/NIDDK-funded R01 project
(DK123334), which was initiated in December 2020 for a five-year period. The parent study aims to compare the
4-week effects of frequent, short bouts of physical activity (PA) designed to interrupt prolonged sedentary
behavior (SB, i.e., sitting) versus a single continuous daily PA bout of equal total duration, focusing on their
impact on glucose control and the underlying mechanisms in adults with prediabetes.
The PI, a mid-career researcher, faced significant challenges during the initial years of this R01, including
launching a new clinical research study and assembling a team during the COVID-19 pandemic, as well as
navigating the demands of new parenthood following the birth of her first child in Spring 2022. These factors
inevitably impacted her work productivity. Despite these challenges, the study has successfully randomized 35
out of the planned 66 participants, with primary outcome data collection completed for 32 participants. Additional
pilot grants have enabled the extension of the intervention from 4 weeks to 12 weeks, along with a 3-month
follow-up and expanded data collection. With over 60% of the data now collected, the focus is shifting to the
critical tasks of creating a central database, data cleaning, and analysis to accelerate the generation of
interpretable preliminary data.
The supplemental funding is sought to hire a new PRA with skills and experience in database management, data
cleaning, coding, and analyses. Three specific aims will be addressed. Aim 1 involves the analysis and
interpretation of daily PA and SB data, along with 24-hour glycemic variability, including an exploratory analysis
to better understand the interaction of these factors in free-living conditions. Aim 2 focuses on the analysis of
24-hour substrate oxidation and glucose kinetics using the combination of whole-room calorimetry and a dual-
tracer technique to explore how different PA patterns influence glucose metabolism. Aim 3 proposes to explore
whether distinct glycemic phenotypes are associated with changes in traditional markers of glucose metabolism
following the interventions, potentially leading to personalized strategies for T2D prevention.
This funding is crucial for accelerating data analysis, facilitating the timely dissemination of findings, and
generating the preliminary data necessary to develop a new, competitive R01 proposal. It will also give the PI
the time needed to focus on manuscript preparation and grant writing, thereby advancing her project and
ensuring her retention and success in academia. Ultimately, these data will contribute to scientific and public
health efforts aimed at optimizing PA interventions for T2D prevention.

Public health relevance
NARRATIVE This proposal seeks additional funding to support an ongoing NIH-funded study that examines whether and how breaking up prolonged sitting—a potentially accessible and practical strategy—can improve glucose control in adults with prediabetes, a population at high risk for developing type 2 diabetes. Despite challenges posed by the COVID-19 pandemic and the lead researcher's new parenthood, the study has made significant progress. The requested funds will accelerate and complete the data analysis, enabling the team to identify the most effective strategies for diabetes prevention and ensure the continuation of this critical research.